Amadorins as a Novel Oral Therapeutic for Diabetic Retinopathy

PROJECT SUMMARY
Diabetic Retinopathy (DR) is a serious diabetic complication that is the leading cause of vision loss in working-
age adults, affecting more than 7.5 million people in the USA. It causes more new cases of blindness than any
other eye disease in people between the ages of 18 and 65. The anti-VEGF treatments can slow the progress
of DR in many patients but are only used after significant vascular lesions have already developed. These
intraocular antibody injections are expensive, painful, inconvenient for patients and introduce a risk of developing
endophthalmitis. The successful development of an orally administered small molecule therapeutic that protects
the retina at an earlier stage of the disease would represent a significant breakthrough in the clinical management
of this diabetic complication. Praetego Inc. plans to address DR by developing a novel oral medication that may
protect the retina from the damage of hyperglycemia at the earliest stages of the disease. Hyperglycemia is the
key common factor linking all diabetic complications. Direct reaction of proteins with glucose leads to formation
of so-called advanced glycation end products (AGEs), a process accompanied and accelerated by production of
damaging dicarbonyls such as methylglyoxal, reactive oxygen species and free radicals. There is much evidence
implicating AGE formation as a causative factor in all microvascular complications of diabetes. Our project
advances our novel and potent AGE inhibitor, PTG-630, for treating DR, which is demonstrating neuroprotection
in preclinical studies on diabetic peripheral neuropathy (DPN). It avidly binds redox metal ions, especially Cu2+,
which endows it with the additional capacity to be a general antioxidant. PTG-630 has been well characterized
in safety pharmacology and ADME (absorption, distribution, metabolism, excretion), and physical-chemical
properties. This dual-acting small molecule has excellent penetration into the brain and CSF after oral
administration due to its excellent cellular permeability. In preliminary pharmacokinetic studies, we have
confirmed that it quickly reaches the retina, an organ where there is evidence of neurovascular damage
preceding vascular lesions in DR. Thus, in this Phase I proposal, we will test the hypothesis that: orally
administered PTG-630 can prevent retinal neurodegeneration, vision loss and retinal inflammation in STZ-
diabetic rats. Our Specific Aims are: 1) determine the effectiveness of PTG-630 (in its tri-HCl salt form) to prevent
vision loss and diabetes-induced retinal disease in the streptozotocin (STZ)-diabetes model using female Long-
Evans rats; and 2) do the same in male Long-Evans rats. We will accomplish this by a) measuring visual function
through behavioral optokinetic analysis, using spatial frequency threshold and contrast sensitivity; b) measuring
inner and outer retinal thickness using spectral domain optical coherence tomography (SD-OCT); and c)
measuring AGE accumulation, macro-glial reactivity, and retinal ganglion cell survival. Successful completion of
this project will provide data supporting more thorough studies by a planned Phase II STTR submission while
helping prepare for IND-enabling studies following an early pre-IND FDA meeting.

Public health relevance
PROJECT NARRATIVE Diabetic Retinopathy (DR) is a serious and prevalent complication of diabetes and the most common cause of vision loss in working-age Americans. The risk of developing diabetic complications is strongly linked to hyperglycemia, and one of the most likely mechanisms of these complications is the formation of advanced glycation end-products (AGEs). We aim to develop a novel protective compound, PTG-630, a potent “Amadorin” that inhibits AGE formation, for oral delivery as a new approach to slow or prevent the development of DR.